Discovering and Exploiting Selectivity within Tandem Bromodomains

PROJECT SUMMARY
The goal of this administrative supplement request is to provide a state-of-the-art crystallization instrument for
structural studies of bromodomain binding to metabolically-derived histone acyl-lysines and small-molecule
inhibitors covered by the R35 GM128840 parent award. The role of bromodomain-regulated transcription in
human disease is well appreciated with bromodomain inhibitors in clinical trials. Despite these achievements,
several critical questions remain. For example, bromodomains are localized disproportionately at super-
enhancers. The basis of this localization is unknown but important given that super-enhancers are enriched at
loci with oncogenic potential. We hypothesize that tandem bromodomains act as a scaffold for acetylation-
dependent chromatin reorganization, for instance, joining promotors with enhancers to drive transcription
(Focus 1). We are taking a structural and biophysical approach to investigate the role of tandem
bromodomains in maintaining chromatin conformations. We also hypothesize that metabolic changes induce
post-translational modifications on histones “read” by bromodomains. Yet, the acylation and protein binding
specificity of bromodomains are poorly understood. To address this metabolic question, we use biophysical,
structural biology, and proteomic techniques to investigate bromodomain acylation selectivity and link acyl-CoA
metabolism with transcription (Focus 2). To aid mechanistic inquiries, we are developing inhibitors of
bromodomains using a novel fragment-based NMR screening strategy with a current focus on the PBRM1
bromodomains (Focus 3). These chemical tools will distinguish the differential activities of bromodomains in
disease models and lead to therapeutics targeting the PBRM1 axis in cancer. To determine optimal conditions
toward x-ray structure determination of bromodomains bound to ligands, the proposed instrumentation
provides the necessary platform and infrastructure to screen and automate several orders of magnitude
greater than a single dispenser can perform. Furthermore, this screening platform will be used for collaborative
projects for the Program in Chemical Biology at the Medical College of Wisconsin (MCW) and open to all MCW
investigators. The instrumentation will be installed in the shared crystallization instrumentation room controlled
by the Department of Biochemistry. As this instrumentation will replace obsolete 14-year-old instrumentation,
this room is equipped with the necessary space and infrastructure for the installation and operation. The
instrumentation will be maintained by PhD-level research-track faculty and staff. Consistent with its record of
significant investments in biophysical research infrastructure and facilities, MCW has committed funds toward
the total cost, space to house the requested instrument, 50% of the expenses for its maintenance, and salary
support for training and supervision.

Public health relevance
PROJECT NARRATIVE While the sequence of DNA defines what proteins are possible, which of these many DNA sequences are made into proteins is determined by “epigenetic” modifications that occur on top of (“epi”) the DNA sequence (“genetics”). The precise and combinatorial location of these modifications on the DNA sequences is controlled by proteins that “write,” “read,” and “erase” epigenetic modifications. Our research focuses on a class of proteins that “read” epigenetic modifications, which are implicated in a wide range of human diseases including cancer and diabetes, with the long-term goal of developing novel ways to target these proteins with small molecule drugs and chemical probes.